Clinical Core

PROJECT SUMMARY – Clinical Core
The Clinical Core supports patient-centered HIV/AIDS research through activities and services: (1) facilitating
access to key populations of people with HIV (PWH), patient-derived biologic specimens, and relevant
databases, in both domestic and international settings; (2) providing consultation to address clinical challenges
consistent with NIH HIV/AIDS research priorities, including study design and implementation, and sophisticated
domestic and international regulatory support; and (3) serving as the liaison for community engagement in
CFAR research. The Core is involved in recruitment and enrollment of PWH and biologic specimens through
Duke University and partnering institution clinics, coordinating access to the Duke CFAR Biorepository and
support to access Network repositories. Importantly, the Clinical Core is intimately involved in prevention and
treatment efforts for the Southern HIV Epidemic, and HIV-related co-morbidities, through research on pre-
exposure prophylaxis, acutely infected persons, substance abuse including persons who inject drugs, and
retention in care for marginalized populations, as well as through outreach to historically black colleges and
universities. The Core has identified high-value, well-phenotyped populations through the Duke CFAR
Biorepository, especially useful for investigators researching co-morbidities, recently infected persons, and
long-term non-progressors. The Clinical Core leadership and staff are highly experienced and active, and
since 2015 the Core has provided 226 consultations on study design and implementation, regulatory support
on 601 applications, and assistance with subject recruitment in 14 studies. The Clinical Core is highly
networked within the CFAR, and with other entities both internal and external to Duke. Notably, the Core has
supported the opening of an HIV Vaccine Trials Network site at Duke, creating exciting new opportunities for
vaccine-related science. The Core serves as the gateway to access our international partners in Tanzania,
Kenya and South Africa, and populations of PWH. These networks have attracted investigators new to
HIV/AIDS, which has further enhanced the impact of Clinical Core researchers. The Clinical Core welcomed
seven new Duke faculty as Core investigators, and in conjunction with other CFAR Cores, plays an important
role in their co-mentorship, promoting highly rigorous, impactful, and ethically sound investigations. In the next
funding cycle, the Clinical Core expects continued expansion of research activities focused on the Southern
HIV Epidemic, with partnerships in other academic institutions, public health professionals, and the community,
building upon our work in HIV testing, prevention, early treatment, and retention in care. The Core anticipates
increased activities in HIV-related co-morbidities, especially with our international partners. Growing expertise
and research in HIV-related cardiovascular disease and disparities in the care of HIV-related CVD within the
Clinical Core will lead to exploration of a new Scientific Working Group focused on Health Services Research.